TOX-driven CD8 T cell differentiation and dysfunction in tumors

PROJECT SUMMARY
CD8 T cells specific for cancer cells are found within human tumors, but despite their presence, tumors
progress, suggesting that T cells become unresponsive. To design predictably effective
immunotherapies, we must elucidate the mechanisms controlling tumor-specific T cell dysfunction. We
previously demonstrated that T cells in tumors enter an epigenetically encoded dysfunction state that
becomes resistant to therapeutic reprogramming and found that TOX, a DNA-binding protein, is a key
regulator enforcing the dysfunctional state. The factors that drive TOX expression, and how TOX
precisely establishes the dysfunction program remain largely unknown. TCR signal strength impacts T
cell differentiation, and while we know that antigen chronicity is a key driver of TOX-driven T cell
dysfunction, we do not know how signal strength of chronic tumor antigen impacts TOX-driven
dysfunction and amenability to immunotherapeutic reprogramming. In this application, we will determine
how signal strength regulates TOX and TOX-driven dysfunction programs in mouse and human tumors,
ask how TOX induces and maintains dysfunction, and target TOX and its downstream mediators to
uncover the mechanisms underlying dysfunction imprinting. To achieve these goals, we will utilize
clinically relevant genetic cancer mouse models and track T cells longitudinally within progressing tumors
while encountering tumor antigens with varying signal strength. We will employ transcriptomic and
epigenomic methods and innovative protein degradation strategies to determine what controls TOX, how
TOX induces and/or maintains dysfunction, and how TOX downstream mediators regulate the epigenetic
programs associated with plasticity and dysfunction imprinting. We will leverage human neoantigen-
specific tumor-infiltrating T cell resources to understand how TCR signal strength determines TOX-
dependent molecular signatures and functional states of T cells in human tumors. Importantly, we will
test and design strategies to target TOX and TOX downstream mediators to improve cancer
immunotherapy.

Public health relevance
PROJECT NARRATIVE CD8 T cells are powerful immune cells that specifically recognize infected cells, and in some settings cancer cells, and eliminate them. However, CD8 T cells in cancer patients fail to eliminate cancer cells because T cells become hyporesponsive. We propose to understand the mechanisms that drive T cells into cancer-induced hyporesponsiveness and test strategies to reprogram T cells into effective cancer killing immune cells.